Mechanistic Understanding for the Role of Lin28b in Pancreatic Cancer Progression

Project Summary
Pancreatic ductal adenocarcinoma (PDA) is a leading cause of cancer-related death in the US, for which
treatment remains basically unchanged in the past three decades. Although patients often die from metastatic
lesions, there are no specific diagnostic markers or therapeutic strategies aimed at treating metastases,
particularly due to an almost complete lack of knowledge on the molecular drivers of metastatic progression.
Using a combination of comparative transcriptomics and a novel functional soft-agar screen, we identified a
new factors, DennD5b (DENN domain containing 5b, a RAB-GEF protein of unknown function), that is
specifically expressed in metastatic lesions and its inhibition completely halted the growth of metastases
without affecting the primary tumors; furthermore, preliminary data indicate that DennD5b modulates lipid
metabolism, providing metabolic fitness to these metastatic cells, all together indicating that these lesions
evolve by acquiring non-genetic adaptations. In this proposal, we will take advantage of biochemistry, cell
biology, metabolomics and genetically-engineered mouse models in order to molecularly characterize this
factor, with the potential to change treatment for this devastating disease.

Public health relevance
Project Narrative Pancreatic cancer is the second leading cause of cancer-related death, with less than 5% survival after 5 years; although patients succumb to metastases, there are no specific diagnostic markers or therapeutic strategies aimed at treating metastases, particularly due to an almost complete lack of knowledge on the molecular drivers of metastatic progression. Using a combination of comparative transcriptomics and a novel functional screen, we identified a specific new factor, DennD5b, that is expressed in metastatic lesions and their inhibition completely halted the growth of metastases without affecting the primary tumors; furthermore, preliminary data indicate that they may provide metabolic fitness for metastatic cells to grow in these foreign niches, indicating that these lesions evolve by acquiring non-genetic adaptations. In this Supplement, we will take advantage of biochemistry, cell biology, metabolomics and mouse models in order to molecularly characterize this factor, with the potential to change treatment for this devastating disease.